Cedars Sinai Center for the Chronic Pancreatitis Clinical Research Consortium

This is an application for renewal of Clinical Center designation from the Cedars-Sinai Center for the Chronic
Pancreatitis Clinical Research Consortium.
The Cedars-Sinai Clinical Center has provided considerable leadership in the organization and progress of the
Consortium for the Study of Chronic Pancreatitis, Diabetes, and Pancreatic Cancer (CPDPC), the former name
of the Consortium. Dr. Pandol co-chairs the Steering Committee and Ancillary and Associated Studies
Committee while Dr. Goodarzi co-chairs the T3cDM Working Group and, as chair of the Genetics Committee,
leads the Consortium’s initiatives to define the genetic risks of pancreatitis and T3cDM. We have successfully
addressed challenges in recruitment and retention of subjects in the cohort studies to significantly improve our
performance, as described in this application. Moreover, we have completed or are performing several ancillary
studies including epidemiologic and genetic studies defining the natural history and risk factors for the pancreatic
disorders; biomarkers for early diagnosis; and treatment trials based on our mechanistic research of disease
mechanisms. For the next phase of the Consortium, we are committed to the following Specific Aims:
Aims
1. Continue recruitment and retention of subjects in CPCRC cohort studies (PROCEED, INSPPIRE 2).
2. Continue currently supported ancillary and associated studies elucidating the pathophysiology and testing
treatments for pancreatic diseases.
3. Continue a series of studies that combine clinical features with genetic susceptibility to allow for the prediction
of future development of diabetes in patients with chronic pancreatitis.
4. Determine the role of pancreatic enzyme replacement in improving glucose homeostasis in patients with
chronic pancreatitis and diabetes, with or without pancreatic exocrine pancreatic insufficiency.
5. Develop novel approaches for treatment and symptom management for patients suffering from non-
malignant pancreatic diseases.
We will carry out the aims with a leading interdisciplinary team committed to collaborative research with other
Centers and the Data Coordinating Center (DCC) of the Consortium to continue to address and resolve the
outstanding gaps in the field.

Public health relevance
This is an application from the Cedars-Sinai Center for the Chronic Pancreatitis Clinical Research Consortium. The Cedars-Sinai Center will contribute to the overall goals of the Consortium to elucidate the pathogenic basis of clinical outcomes progression; and (b) to develop new means of diagnosis, treatment, and clinical management of chronic pancreatitis and its complications, including chronic pain, pancreatic insufficiency, and pancreatogenic diabetes (type 3c diabetes mellitus, T3cDM), and to understand their pathogenic interrelationships.